Whole organ transcriptome reconstruction by dimensionality reduced fluorescent in situ hybridization

Project Summary
In biology, structure determines function. To understand the function of organs (i.e., physiology), we must obtain
structural information on the organs’ structure (i.e., anatomy). Mapping organs’ structures must occur at
(sub)cellular spatial resolution with sufﬁcient details on cells’ molecular states. Spatial transcriptomics
technologies have made signiﬁcant advances in mapping thin tissue sections. However, all spatial transcriptomics
approaches are restricted to sections thinner than 150 µm, with the vast majority needing to be less than 15 µm.
While 2D sections are informative, sampling 3D organs with 2D sections loses information and provides a partial
view of the organs’ full structure. Here we propose to develop whole organ spatial transcriptomics. Key to our
approach is our recent invention (patent pending) of dimensionality reduced Fluorescent In Situ Hybridization
(dredFISH). Single-molecule FISH approaches, such as smFISH, MERFISH, seqFISH+, and many other variants, label
and count individual RNAs. dredFISH is not a single molecule FISH. Instead, it is designed to directly measure an
approximation of cells’ transcriptional state by measuring multiple distinct weighted sums of thousands of genes.
The transcriptional signatures represented by the distinct sums of genes are generated for the reference scRNAseq
and compared to the ones directly measured by dredFISH. Integrating and harmonizing the directly measured FISH
signatures and the reference data allows the inference of cell types (kNN classiﬁcation) and gene expression
reconstruction (kNN regression). By leapfrogging the need for individual gene measurements, dredFISH achieves
multiple features that make it ideal for fast light-sheet microscopy of thick samples (500 µm). Speciﬁcally, i)
dredFISH is performed using low magniﬁcation objectives (10x, 16x) instead of high magniﬁcation objectives
(60x,100x) used for single-molecule FISH. ii) dredFISH utilizes the tissue clearing and hydrogel embedding
technique used by CLARITY, making it compatible with existing light-sheet imaging protocols. iii) dredFISH signal
comes from the weighted sums of ﬂuorescence from tens of thousands of RNA molecules per cell, each stained by
tens of probes, making it much brighter and easier to measure than all other FISH approaches. Our preliminary
results demonstrate that dredFISH works well in thin 2D sections validating our approach. The goal of this
proposal is to extend dredFISH from 2D to 3D to allow whole organ spatial transcriptomics. This goal will be
accomplished by parallel development steps divided into two aims. Aim #1 will continue optimizing and validating
dredFISH in 2D by changing a few aspects of the method that will ease the transition to 3D. Aim #2 will update
the staining and imaging steps in the dredFISH protocol to make them compatible with thick samples. Aim #3 will
demonstrate the power of dredFISH whole organ spatial transcriptomics by creating the entire mouse brain's cell
type and gene expression atlases. By completing these aims, we will deliver new capabilities: whole organ spatial
transcriptomics that will have transformative effects on numerous biomedical disciplines.

Public health relevance
Project Narrative Spatial transcriptomics technology enables structure-function analysis of tissues at single-cell resolution producing atlases with a broad impact on many biomedical research areas, yet, despite tremendous technological progress in spatial transcriptomics, all existing spatial transcriptomics technologies are limited to thin 2D sections. We propose to develop a new approach for whole organ spatial transcriptomics based on the integration of new ﬂuorescent in situ hybridization technology we invented, scRNAseq reference, and light-sheet microscopy. We will demonstrate the new technology by creating a complete cell type and gene expression atlases of the whole mouse brain.